CONTRACTOR SHALL INTEGRATE THE RESEARCHER AUTHENTICATION/AUTHORIZATION (AUTH) SERVICE (RAS) WITH NIDDK CENTRAL REPOSITORY TO ACCOMMODATE SINGLE SIGN-ON AND LOGIN WORKFLOWS, ALONG WITH ANY ASSOCIATED A

CONTRACTOR SHALL INTEGRATE THE RESEARCHER AUTHENTICATION/AUTHORIZATION (AUTH) SERVICE (RAS) WITH NIDDK CENTRAL REPOSITORY TO ACCOMMODATE SINGLE SIGN-ON AND LOGIN WORKFLOWS, ALONG WITH ANY ASSOCIATED A